Contributions of attentional and inhibitory functioning to saccadic decisions

Project Summary
Saccades are a fundamental behavior that enables functional vision by frequently changing which input receives
foveal processing. Fixations are the moments in time between saccades during which new input is processed,
and the destination of the next saccade is also programmed. Therefore, the decision to produce a saccade is
complex and depends on the interaction of numerous systems. Saccadic behavior differs widely across a range
of clinical states, and differences emerge in infancy. A large literature has investigated the dynamics of saccadic
decisions through computational modeling and neurophysiological data. However, relatively less is known about
individual differences within the typical population. The objective of this proposal is to identify underlying
mechanisms that explain individual differences in fixation duration tendency, and to investigate how they affect
downstream attentional selection. In Aim 1, independent measures of attentional and inhibitory functioning will
be compared against individual fixation duration variability. Psychophysical thresholding will determine sensitivity
to peripheral targets at a range of eccentricities while fixation is maintained. Thus, individual differences in ability
to detect task-relevant peripheral information, critical for planning a saccade, will be measured. Inhibitory function
will be estimated as stop-signal reaction time (SSRT) obtained from a saccadic countermanding task. Inhibition
plays an important role in slowing accumulation to prevent motor units from reaching threshold quickly. Previous
results show that individuals with longer initial fixations make larger amplitude saccades and may land closer to
a target. Therefore, enhanced peripheral detection abilities are hypothesized to cooccur with longer fixation
duration tendencies. Alternatively or in addition, individual inhibitory function is hypothesized to prevent fast
saccades and extend fixation durations. Aim 2 will investigate how individual tendency for short fixation durations
affects the choice of saccade destination. This aim uses more complex search displays than Aim 1, with strong
competition from salient distractors. A novel hypothesis is proposed about the relationship between individual
differences in SSRT and oculomotor capture: individuals with longer SSRT will produce more fast saccades to
salient distractors. Finally, Aim 3 will use novel methodology to investigate individual differences in fixation
duration known to occur during extended viewing of natural scenes. A dynamic useful field of view (UFOV) task
will use gaze-contingent probe presentation at precise eccentricities to measure individual sensitivity to
peripheral information during free-viewing. This measure of peripheral processing will more directly mirror
conditions present during natural vision, and these measures of attentional breadth are predicted to relate to
individual differences in fixation behavior during free-viewing of natural scenes. The long-term goal is to bridge
a gap between theories from computational models of neurophysiological data and human saccadic behavior.
Understanding the etiology of oculomotor behavior can help target treatments for disorders and shed light on
how individual variability might alter visual information acquisition and environmental interactions.

Public health relevance
Project Narrative The proposed research will identify mechanisms that contribute to individual differences in saccadic decision timing within the typical population and investigate their downstream consequences on processing selectivity. Differences in eye movement tendencies occur in infancy, as well as across a wide range of clinical populations, and the current research can help uncover how attentional and inhibitory processing relate to their etiology. In the long-term, this would potentially assist in developing better eye movement models, targeting treatments for dysfunction, and understanding how variability in the typical population may affect information acquisition and behavioral outcomes in real-world environments.